Integrated Care Core

INTEGRATED CARE CORE ABSTRACT
Meta-analyses have established the efficacy of a broad range of treatments for common mental disorders (such
as depression, anxiety and PTSD). Moreover, the feasibility of integrating efficacious mental health services and
HIV prevention and treatment has been demonstrated, with integration shown to be an efficient strategy for
increasing access to effective mental health care and improving HIV outcomes. However, evidence-based
mental health treatments are not typically available as part of routine HIV prevention and treatment services,
compromising both mental health and HIV outcomes. The Integrated Care (IC) Core of the UW D-ARC aims to
help bridge this “know-do” gap so that mental health treatments shown to be effective in research trials are
actually delivered to people living with or at risk for HIV. IC Core efforts will be guided by an Institute of Medicine
framework for establishing the evidence base of psychosocial interventions (IOM). The Core leverages unique
strengths in (a) integrated care at the UW Departments of Psychiatry & Behavioral Sciences and Global Health
and (b) HIV research and services available through the UW/Fred Hutch CFAR and two federally funded
education and training centers that provide technical assistance to a large group of local, regional and global
HIV care providers. Led by a diverse, multidisciplinary team, the IC Core will unite regional and global HIV care
providers with UW researchers to generate research aligning with the IOM framework and bridging the gap
between research and practice. The Core features innovative strategies to engage community partners (peer-
to-peer learning networks), provide expert consultation on research proposals (Idea Development Workshops),
and disseminate new findings (annual writing workshops as well as publications and webinars coordinated with
the Mental Health Innovation Network). The Core will award two Community-Centered Pilot AIDS Research
Center (C-PARC) grants to partnerships between UW faculty and HIV care provider organizations to incentivize
collaborations. By supporting the development of new researchers and new collaborations between researchers
and HIV care partners both local and global, the Core aims to establish an infrastructure for ongoing and
meaningful engagement of community partners in research that will lead to impactful, innovative research and,
ultimately, accelerate an end to the HIV epidemic.